EVALUATION OF TREATMENT REGIMENS IN CHILDHOOD ACUTE LYMPHOID LEUKEMIA

Four different consolidation regimens for childhood ALL are being compared in this phase III POG study. The principle questions are the benefit of asparaginase or Ara-C when added to intermediate dose methotrexate and the efficacy of a shorter more intensive consolidation vs. a "spread out" one for both high and low risk patients (POG #8602).